Optimization of the engineered 3D hepatic microenvironment enhances pluripotent stem cell derived hepatocyte

Project Summary/Abstract
Liver disease is a growing clinical problem in the United States and worldwide affecting 30 million Americans
resulting in 750,000 hospitalizations and 36,000 deaths yearly. Unfortunately, unlike other common diseases
such as cardiovascular diseases, the incidence of liver disease and its associated complications are
increasing. Given the steady rise of patients with liver disease, the demand for liver transplantation has
continued to increase while the supply of organs has remained unchanged creating a pressing need to address
this organ scarcity. Proposed alternatives to organ transplantation are the transplantation of cells but human
hepatocytes are similarly difficult to source. As a result, there are currently no alternatives for obtaining robust
functional hepatocytes which is significantly hampering scientific study and the development of more effective
clinical therapies; our work addresses this significant research and clinical gap. Pluripotent stem cell derived
hepatocyte-like cells are often cited as a potential alternative cell source for organ transplants and as a
platform for pharmaceutical and scientific study. However, the current inability to derive robust and fully mature
hepatocytes limits the clinical and scientific utility of currently produced cells. Pluripotent stem cell fate and
hepatocyte maturation is determined by the complex array of internal signals and external cues from the
microenvironment. Unfortunately our current differentiation platforms do not mimic the cellular, extracellular
matrix (ECM), and 3D complexities of the in vivo hepatic microenvironment and therefore the role of ECM-cell
and cell-cell interactions in the differentiation process remains largely unknown. Our central hypothesis is that
the 3D microenvironment and subsequent cellular interactions (e.g. cell-ECM and cell-cell interactions) dictates
cell fate decisions and it is through these factors by which fetal cell types mature into terminally differentiated
cell types. In recent work our group has developed robust tools to systematically and efficiently manipulate the
3D microenvironment. The central goal of this proposal is to identify and examine important inductive cellular
interactions for directed pluripotent stem cell differentiation in vitro to enable the generation of phenotypically
and functionally mature hepatocytes. We will systematically examine and identify the role cell-cell and cell-
ECM interactions play in regulating the fetal to adult hepatocyte transition and will incorporate these findings
into our current differentiation and tissue engineered constructs. These optimized 3D multicellular spheroids
platforms will enable scientific study and the development of more effective clinical therapies.

Public health relevance
PROJECT NARRATIVE Given the steady rise of patients with liver disease in the United States, the demand for liver transplantation has continued to increase while the supply of organs has remained unchanged creating a pressing need to address this organ scarcity. Stem cell derived hepatocytes are often suggested as an alternative cell source for organ transplants, however, the current inability to derive robust and fully mature hepatocytes limits their clinical and scientific utility. The goal of this proposal is to identify and examine important cellular interactions for directed hepatocyte maturation in vitro.